Circuit architecture and dynamics in odor representation and perception

7. Project Summary/Abstract.
In the mammalian brain, early sensory areas are organized as stereotyped maps of stimulus qualities. The
anatomical features of these sensory maps underlie the neuronal computations and information processing
that are essential to generate appropriate perceptual experiences and behaviors. In the mammalian olfactory
system primary olfactory sensory neurons (OSNs) expressing the same odorant receptor converge their axons
into the same insular glomerular structure in the olfactory bulb. The mitral/tufted cells in the bulb received
exclusively input from single glomeruli, but they project to various cortical areas with divergent output patterns.
There are also extensive intercortical connections with no apparent anatomical mapping. It is not well
understood how this pattern of strict convergence and segregation contributes materially to the processing of
olfactory information and odor-driven behaviors. Nor is it understood the role played by the intercortical
connections in the process of odor information. In this project, we establish a multi-disciplinary approach to
determine the contribution of intercortical connections to odor representation and perception. Specifically, we
will use activity marking to determine the stable representation of odors in various cortical areas and test the
hypothesis that intercortical interactions stabilize odor representation.

Public health relevance
8. Public Health Relevance. Interneuronal connection in the nervous system is essential for the proper function of the brain. Cognitive deficits in many psychiatric disorders arise from disruptions in neural connectivity, including disruptions within sensory circuits. The proposed study investigates the role of intercortical neuronal connections in in regulating sensory information processing and perceptual experience. Results from this study will reveal how brain function can deteriorate because of disruptions in the normal connection patterns among neurons. This information is important to provide deep understanding of normal and pathological function of the nervous systems.